AZT THERAPY FOR PATIENTS WITH AIDS ASSOCIATED KAPOSI'S SARCOMA

The objects of this study are to determine if AZT prolongs the survival and decreases the incidence of opportunistic infections in patients with AIDS/KS, to assess the degree of its safety and efficacy and to evaluate the efficacy of alternative schedules of AZT.